Early-Stage Clinical Trial of AI-Driven CBCT-Guided Adaptive Radiotherapy for Lung Cancer

According to NOT-OD-24-001, the parent abstract is at the beginning of the research strategy:
“The Research Strategy section should include a summary or abstract of the funded parent
award”

Public health relevance
According to NOT-OD-24-001, a project narrative is not applicable.